Optimizing an automated chatbot to achieve efficient, scalable treatment for eating disorders

PROJECT SUMMARY/ABSTRACT
Eating disorders (EDs) are common, disabling, and costly, yet less than 20% of those with EDs ever receive
treatment. As such, our team established a coached app for EDs. Though coached apps are lower cost relative
to therapy, they come with significant implementation barriers given the need for human support. One solution
is to program chatbots that mimic aspects of human coaching. Still, it is recognized that engagement with
digital mental health interventions can be challenging, making it important that an ED treatment chatbot be
efficient, ideally with the most effective components delivered first. To date though, little is known about which
components are most effective in reducing ED symptoms. The goal of this study is to fill this gap by optimizing
an automated chatbot program to treat EDs. We will build on our programmatic research in this area and prior
use of the multiphase optimization strategy (MOST) to test four candidate ED treatment components in an
optimization randomized control trial (ORCT). These candidate components, which map onto ED putative
mechanisms, target: 1) overevaluation of weight/shape; 2) dietary restraint; 3) emotion dysregulation; and 4)
resisting urges to binge. Our multidisciplinary, multisector team has experience developing, evaluating, and
deploying digital ED interventions. We include industry and non-profit partners, including the National EDs
Association (NEDA; largest EDs non-profit in the U.S.), assuring real, sustained impact. For our ORCT, we will
enroll N=800 adults who screen positive for an ED and are not in treatment, recruited through NEDA’s online
EDs screen, which reaches 200K+ per year, or social media. We will randomly assign participants in a
carefully-balanced 24 factorial design to receive some combination of the candidate ED treatment components
(i.e., each combination from zero components to four components). In Aim 1, will estimate the individual and
combined contributions of the four candidate ED treatment component on changes in ED psychopathology, as
well as on ED behavior frequencies, comorbid symptoms, and clinical impairment at 1-, 2-, and 6-months post-
randomization. We will also examine moderation of component effects. In Aim 2, we will examine the effects of
each candidate component on its proposed target, and determine if those changes are associated with
reductions in overall ED psychopathology. Finally, in Aim 3, we will identify the optimized chatbot package that
is effective, producing the best expected improvement in ED outcomes, while remaining efficient in the use of
participant time. We will also explore component ordering that may best accommodate participants with
different engagement levels. To inform decision-making about immediate dissemination of the optimized
chatbot, we will compare the optimized chatbot to the control version. We will also identify any differences in
the optimized chatbot as a function of participant priorities and characteristics (personalization). This study has
high potential to offer streamlined EDs care via a chatbot that can be scaled infinitely, along with real impact
nearly immediately, rather than the long translation gap widely discussed.

Public health relevance
PROJECT NARRATIVE Eating disorders are common, serious mental illnesses, but less than 20% of individuals with these disorders ever receive treatment. A scalable solution to this problem is to program a rule-based chatbot to deliver cognitive-behavioral therapy (CBT) and mimic aspects of human support; however, engagement with digital interventions is challenging and thus the chatbot needs to be efficient and targeted. The goal of this study is to fill this gap by optimizing an automated chatbot program to treat eating disorders, ultimately resulting in a infinitely scalable, evidence-based, digital intervention for this major public health problem, with high potential for real impact nearly immediately given our established multi-sector partnerships.